SGLT2 inhibitors after acute kidney injury to improve outcomes in type 2 diabetes

PROJECT SUMMARY / ABSTRACT
The safe and effective ways to care for patients after acute kidney injury (AKI) is a significant unknown in the
medical field and one of growing attention. There is significant uncertainty about use of kidney-protecting
medications in patients who have had AKI because many of those medications, paradoxically, reduce kidney
function when initiated or resumed before their kidney-protecting qualities become apparent. This leads to
deferral of therapy for many patients who have had recent AKI and other risk-factors, like chronic kidney
disease (CKD) and diabetes mellitus. These patients are actually at heightened risk for multiple adverse
outcomes that kidney-protecting medications prevent. Such deferrals may even become indefinite. The newest
of these medication classes being impacted by these post-AKI practices are sodium-glucose cotransporter-2
(SGLT2) inhibitors, which are first-line therapy for type 2 diabetes and are known to prevent progression of
CKD and cardiovascular events. Observational studies, including those published by the applicant Dr. Daniel
Murphy, show favorable outcomes when SGLT2 inhibitors are provided after AKI to those with type 2 diabetes.
Now Dr. Murphy seeks to translate these findings into a pilot, pragmatic, cluster-randomized clinical trial (RCT)
based in primary care clinics to demonstrate the feasibility of an intervention to increase use of SGLT2
inhibitors after AKI (Aim 1). Nested within the pilot RCT, Dr. Murphy seeks to conduct a qualitative study
focused on the experience of primary care providers and pharmacists and, separately, patients, within the pilot
RCT. These interviews will identify barriers to prescribing, receiving, and taking a SGLT2 inhibitor and the
perceived impact of our study’s intervention, which will help Dr. Murphy craft changes to the study intervention
for designing a future RCT based on all his K23 results (Aim 2). In parallel with these efforts, Dr. Murphy will
use electronic health record-data from patients with type 2 diabetes and AKI to determine predictors of SGLT2
inhibitor receipt, which could be used in identifying patients to recruit for a future RCT after this pilot study (Aim
3). Paired with applicable training, these research questions in this K23 Mentored Patient-Oriented Research
Career Development Award will position Dr. Murphy as an independent clinical researcher equipped in both
pragmatic RCT design and conduct alongside his skillset in using observational data to identify potential
treatments and strategies that may improve clinical outcomes. His career will include investigating treatments
to care for patients who have suffered AKI though observational and interventional means.

Public health relevance
PROJECT NARRATIVE Patients who experience acute kidney injury (AKI) are at risk for subsequent progressive kidney disease, cardiovascular events, and death. We propose 1) a pilot cluster randomized clinical trial (RCT) to evaluate the feasibility of an electronic health record-based intervention to increase use of sodium-glucose cotransporter-2 (SGLT2) inhibitors for the treatment of type 2 diabetes among patients who have recently suffered AKI, with 2) a qualitative evaluation of the intervention among stakeholders nested within the RCT, and 3) a retrospective cohort study to identify predictors of SGLT2 inhibitor use. Results will inform the design of a future RCT with the goal of improving outcomes among AKI-survivors.